Signaling-pathway-based preventative strategies for alcoholic liver disease

DESCRIPTION (provided by applicant): Alcohol-induced liver damage is a common liver disease that is due in part to dysregulated lipid metabolism and inflammation. Alcoholic liver disease (ALD) progresses through four pathological stages: steatosis, steatohepatitis, fibrosis and cirrhosis. There is a strong link between the severity of lipid accumulation and the development of liver toxicity. Increased hepatic lipid accumulation enhances the ability of xenobiotics and endotoxins produced in the gut to potentiate alcoholic hepatitis and fibrosis, likely by increased inflammatory signaling, which is dependent on Kupffer cell/hepatocyte interactions and other immune cells. Peroxisome proliferator-activated receptor-a (PPARa) has a central role in regulating fatty acid catabolism in liver. Given the significance of lipid accumulation in the etiology of ALD, it is not surprising that Ppara-null mice exhibit exacerbated ALD as compared to mice expressing a functional PPARa. In contrast to PPARa that regulates lipid catabolism, it was recently shown that PPARβ/d also modulates hepatic lipid metabolism by inhibiting hepatic lipogenesis by inducing expression of insulin-induced gene-1 (Insig-1), an endoplasmic reticulum protein that inhibits SREBP activation. Preliminary data will establish that PPARβ/d can protect against liver damage by toxins, supporting the hypothesis that PPARβ/d will also protect against ALD, an idea that has not been examined to date. Coupled with strong evidence that PPARa and PPARβ/d have potent anti- inflammatory activities, the focus of this application is on elucidating the mechanisms by which PPARa and PPARβ/d regulate hepatic lipid accumulation and hepatic inflammation, two known pathways critical in mediating ALD. Specific aim 1 will use the Ppara-null and Pparb/d-null mouse models to distinguish between the suitability of targeting these receptors to inhibit early and/or pre-existing ALD and the mechanisms by which PPARa and PPARβ/d modulate hepatic alcohol-induced toxicity. Evaluation of PPAR agonism in these models will be evaluated by comparing gene expression and targeted metabolomic profiles with liver pathology to mechanistically delineate how PPARa and PPARβ/d regulate hepatic lipid metabolism in an ALD model. Specific aim 2 will use innovative and novel transgenic mouse models to determine if inflammation modulates PPAR-dependent hepatic lipid accumulation in promoting ALD and to distinguish between somatic cell- mediated inflammation (e.g. hepatocyte) versus immune cell-mediated inflammation (e.g,. Kupffer cell, neutrophils, lymphocytes). Results from this application will determine whether combining ligand activation of PPARa and PPARβ/d and/or inhibition of p38-dependent inflammation will improve approaches to prevent or treat ALD with a solid mechanistic rationale. This application combines the unique expertise and experience of Dr. Albert J. Fornace's laboratory (Georgetown University) and Dr. Jeffrey M. Peters (Penn State University) to define the PPAR regulatory and inflammation-dependent inducing mechanisms that are essential for ALD. PUBLIC HEALTH RELEVANCE: Alcohol-induced liver damage is a common liver disease with important health and socioeconomic consequences that is due in part to dysregulated lipid metabolism and inflammation. This application combines the unique expertise and experience of Dr. Albert J. Fornace's laboratory (Georgetown University) and Dr. Jeffrey M. Peters (Penn State University) to define lipid metabolism regulatory and inflammation-dependent inducing mechanisms that are essential for alcoholic liver disease. Results will improve approaches to prevent or treat alcoholic liver disease with a solid mechanistic rationale.

Public health relevance
Project Narrative Alcohol-induced liver damage is a common liver disease with important health and socioeconomic consequences that is due in part to dysregulated lipid metabolism and inflammation. This proposal combines the unique expertise and experience of Dr. Albert J. Fornace's laboratory (Georgetown University) and Dr. Jeffrey M. Peters (Penn State University) to define lipid metabolism regulatory and inflammation-dependent inducing mechanisms that are essential for alcoholic liver disease. Results will improve approaches to prevent or treat alcoholic liver disease with a solid mechanistic rationale.